Sex-specific effects and the role of ovarian hormones in striatal-mediated food-seeking

Project Summary
In the United States, women experience a significantly higher prevalence of severe obesity (BMI ≥40 kg/m2)
than men. Among these women, individual differences in susceptibility to weight gain positively correlate with
an underlying predisposition for enhanced Pavlovian motivation for food. In addition, the magnitude of striatal
activation to food cues positively correlates with subsequent weight gain. However, directly examining
relationships between striatal function and propensity for weight gain in humans is difficult. To address this gap,
our laboratory uses selectively bred rats that are obesity-prone (OP) and obesity-resistant (OR). The proposed
studies will provide significant insight into how excitatory neurotransmission is regulated in response to diet
and ovarian hormones to influence cue-triggered urges to seek food. Glutamate is the primary excitatory
neurotransmitter within the central nervous system (CNS) and exerts its actions through binding of ionotropic
(i.e., NMDA, AMPA, kainate) and metabotropic (e.g., mGluRs) receptors. Glutamate receptors within the
striatum, and in particular the nucleus accumbens (NAc), are important for both natural reward processing and
addiction. Thus, differences in excitatory neurotransmission within the NAc may contribute to a vulnerability for
enhanced food-cue motivation and propensity for weight gain. Furthermore, there is abundant and compelling
evidence of sex differences in both feeding behavior and NAc function. Work from our laboratory has
demonstrated sex differences in excitatory neurotransmission mediated by calcium-permeable AMPA receptors
(CP-AMPARs) within the NAc. Specifically, we have shown that NAc CP-AMPARs are upregulated by brief
exposure to moderately fatty, junk-food (JF) diets in obesity-prone (OP) rats, and that the persistence of this
effect differs in males and females. This plasticity is critical because NAc CP-AMPARs also underlie cue-
triggered food-seeking in OP males. However, very little is known about these behaviors and their underlying
mechanisms in females, or how they may be influenced by ovarian hormones including estrogens. To address
these gaps in knowledge, studies in this proposal will characterize Pavlovian motivation across the cycle in OP
and OR females, as well as identify a potential role for NAc CP-AMPARs in cue-induced food-seeking (Aim 1).
In addition, this proposal will directly examine the influence of estrogen on excitatory neurotransmission in the
NAc (Aim 2). This work will provide significant insight into the neurobiology food motivation and glutamatergic
plasticity in females.

Public health relevance
Project Narrative As the prevalence of obesity continues to rise, its associated comorbidities pose a significant health risk and financial burden. Using a preclinical rodent model, this proposal examines the neurobiology of eating behavior in individuals who are protected against or at risk for weight gain. These studies will provide important insight into how sex hormones interact with the brain regions to promote over-eating.